CRCNS: US-France Data Sharing Proposal: Open science & cloud computing of MEEG

This data sharing proposal between existing collaborators in the USA and France will expand the
functionality and also user base of a cloud-based computing platform [brainlife.io] devoted to the storage,
curation, analysis, sharing and publication of neuroimaging data. Currently, users of brainlife.io interact and
analyze magnetic resonance imaging [MRI] based data on the platform, which is capable of very
sophisticated analyses of brain structure and function. Here, our specific goal is to expand the capabilities
of this platform to handle human neurophysiological data for the first time – specifically magneto-
encephalographic and electroencephalographic [MEEG] data. The high temporal resolution of MEEG data
significantly enhances studies of brain function in ways that MRI-based brain activity data cannot. By
adding MEEG data to brainlife.io we believe that we can offer the neuroimaging community a unique open
science and data sharing resource that will accelerate scientific discovery in computational, systems,
cognitive and social neuroscience. Why? We plan to implement data analysis ‘Apps’ on brainlife.io that will
allow users to perform sophisticated analyses, e.g. structural and functional connectivity – allowing brain
networks to be better studied by integrating MEEG and MRI-based data. We will implement MEEG ‘Apps’
using 2 widely-used open source MEEG software suites – FieldTrip [MATLAB-based] and MNE Python
[Python-based]. We have the endorsement of the developers of these software packages and, importantly,
the expertise within our team to expand the functionality of brainlife.io. We will also make use of our
scientific expertise – proposing 4 projects that will also make scientific gains in the fields of computational,
systems and cognitive-social neuroscience. Specific Aim 1 [Project 1] presents basic MEEG preprocessing
and processing methods, targeting new users of brainlife.io. Specific Aim 2 [Project 2] provides simulation
tools for evaluating the required statistical power in a MEG experiment prior to running the study –
benefitting both entry-level and sophisticated users. Specific Aim 3 [Project 3] provides tools for source
modelling of MEEG data, as well as providing multimodal datasets in single subjects [from the PI and 3 Co-
PIs] who will be studied in both the USA and French laboratories. Finally, Specific Aim 4 [Project 4]
integrates MEEG data with white matter tracts data in the human brain [based on structural MRI and
diffusion weighting imaging [DWI] data]. This integrative analysis has been generated using our existing
collaboration. Specific Aims 3 and 4 target more mid-level and experienced MEEG scientists.
RELEVANCE (See instructions):
The development and integration of neuroimaging tools across MEEG and MRI-based techniques such as
in this project will directly aid the integrated study of brain functional and structural connectivity across
multiple imaging modalities. This is the next step to developing viable in vivo models of both healthy and
diseased brain function – an essential step for preventing, detecting and treating diseases of the central
nervous system.